CLINICAL INVESTIGATIONS AND CASE REPORTS

Clinical case studies of unusual interest and patient-related research are conducted on a variety of oral and dentally-related subjects within the context of our Oral Medicine training program. The CIPCB sponsors an Oral Medicine Fellowship that provides hospital-trained dentists (1-2/year), interested in a career in academic oral medicine and dental research, with a 3-year, high-quality clinical and basic science research experience. Research techniques range from chart and literature reviews, to the direct evaluation and utilization of advanced diagnostic and therapeutic regimens. Interesting problems of oral pathology, with or without other medical complications, are often seen in the consult clinic. The study and publication of such cases provide valuable information for the practicing dental clinician as well as a rich training experience for the Oral Medicine fellows. The NIDR clinic is a Dental/Oral Medicine consult clinic for all the NIH institutes. Fellows participate in the diagnosis and treatment of medically-compromised patients referred to the clinic and are encouraged to participate in studies of the oral manifestations of systemic disorders and of the oral complications of medical therapy. Particular emphasis is placed on oral mucosal disorders, with special attention to potential saliva/mucosal interactions. The biological/pathophysiologic implications of clinical conditions are discussed and framed into scientific questions with the help of a staff mentor. Collaborations with investigators at other institutes, utilizing the unique patient populations present at NIH, are encouraged.